The Vascular Fibroblast: An Understudied Culprit In Postoperative Venous Stenosis

The Vascular Fibroblast: An Understudied Culprit in Postoperative Venous Stenosis
ABSTRACT
Creating a stenosis-free arteriovenous fistula (AVF) is a significant challenge even for highly skilled vascular
surgeons. The surgery involves anastomosing a vein to a nearby artery in the arm of patients with end-stage
kidney disease (ESKD). However, approximately 40% of newly created AVFs are never usable for dialysis
without subsequent salvage procedures due to significant narrowing in the venous limb of the access (maturation
failure). A major concern is that therapies designed to enhance reendothelialization or inhibit cellular proliferation
have not succeeded in improving surgical outcomes. Consequently, the success of future anti-stenotic therapies
will depend on our ability to update the existing theoretical framework by incorporating evidence emerging from
human observational studies and clinical trials. This translational proposal utilizes emerging transcriptomic data
from individual cells within the human vein and AVF to investigate the mechanisms by which fibroblasts and
myofibroblasts control postoperative inflammation, medial fibrosis, and expansion of the intima that combined
lead to constrictive remodeling and stenosis. Our fundamental hypothesis is that genetic and pharmacological
inhibition of collagen VIII biosynthesis in venous fibroblasts decreases postoperative inflammation, myofibroblast
accumulation, and stiffness in the venous wall, thereby improving AVF maturation. We will test this hypothesis
using an integrated molecular and cellular approach, encompassing in vivo and in vitro models. Aim 1 will
demonstrate the central role of venous fibroblasts in stenotic remodeling of human and murine AVFs. We will
trace the contribution of fibroblasts to the myofibroblast population responsible for the remodeling of experimental
fistulas created in transgenic mice. Additionally, we will investigate the clonal expansion, pro-fibrotic activation,
and fate of human venous fibroblasts after fistula creation using genomic tracing. Aim 2 will demonstrate the
causality of fibroblast-derived type VIII collagen on AVF failure. We will elucidate the upstream mechanisms
responsible for the transcriptional activation of COL8A1 in fibroblasts. We will then demonstrate the role of
collagen VIII as the link between inflammation, fibroblast activation, and excessive extracellular matrix (ECM)
deposition in AVF failure. Mechanistically, we hypothesize that collagen VIII activates the complement C1
complex and Wnt/b-catenin signaling, ultimately leading to exacerbation of both pro-fibrotic and inflammatory
pathways. Lastly, Aim 3 will test the benefits of COL8A1-targeted gene therapy and the anti-fibrotic drug
pirfenidone, which also inhibits COL8A1 deposition, in a preclinical model of AVF failure in swine. We expect to
show that both approaches are feasible and can enhance AVF maturation. We anticipate that these
investigations will provide a comprehensive understanding of the cellular and molecular processes underlying
AVF failure in humans and pave the way for novel therapeutic strategies to enhance maturation and durability of
hemodialysis accesses.

Public health relevance
PROJECT NARRATIVE: Over 800,000 Americans live with end-stage kidney disease (ESKD) and 60% percent depend on a functional vascular access for hemodialysis (HD) treatments. Up to 50% of arteriovenous fistulas (AVF), the preferred vascular access for HD, fail to mature after creation (be usable for dialysis) despite improvements in preoperative planning. The research proposed in this application is relevant to public health because it investigates the role of fibroblasts in the occlusion of veins that leads to failure of the fistula.